New Mexico Food Protection Task Force Meeting and Conference

Project Summary The Southwest Border Food Safety and Defense Center (Center) at New Mexico State University (NMSU) proposes to establish a State Food Protection Task Force program in New Mexico and hold a multiyear statewide conference to initiate the program. The Center was formed as a partnership between the New Mexico Department of Agriculture (NMDA) and NMSU College of Agricultural, Consumer and Environmental Sciences with current members representing several state agencies including the New Mexico Department of Health and the New Mexico Livestock Board. The Center has been instrumental in coordinating local, regional, and statewide events in the area of food safety and defense for more than five years.

Public health relevance
Project Narrative It is widely reported that food-borne disease causes an estimated 76 million illnesses, 325,000 hospitalizations, and 5,000 deaths in the United States each year. The food safety and defense arena is currently evolving due to proposed legislation at the federal level, increased import and export activity, and technology enhancements; the current economic conditions of the country and state will also force the regulatory agencies to evaluate alternatives given tight state and federal budgets challenges. These issues along with an increase in public notification and awareness are the primary reasons to organize a conference plan at the state level. __SpecificAimsTextDelimiter__ The Southwest Border Food Safety and Defense Center (Center) at New Mexico State University (NMSU) proposes to establish a State Food Protection Task Force program in New Mexico and hold a multiyear statewide conference, tentatively scheduled for November 2010 in Albuquerque, NM, to initiate the program. The Center was formed as a partnership between the New Mexico Department of Agriculture (NMDA) and NMSU College of Agricultural, Consumer and Environmental Sciences with current members representing several state agencies including the New Mexico Department of Health and the New Mexico Livestock Board. The Center has been instrumental in coordinating local, regional, and statewide events in the area of food safety and defense for more than five years. It is widely reported that food-borne disease causes an estimated 76 million illnesses, 325,000 hospitalizations, and 5,000 deaths in the United States each year. USA Today reported in an article March 4, 2010, that total costs from food-borne illness in the United States averages $152 billion per year. The estimated costs included medical, death, loss of work, and disability according to data provided by the United States Department of Agriculture and the Centers for Disease Control and Prevention. Recent incidents, such as the Salmonella Montevideo outbreak associated with ground pepper and the hydrolyzed vegetable protein (HVP) product recall, are examples of how wide spread an incident involving food ingredients can be and the associated challenges in containing them. While New Mexico has been in the forefront of identifying several national food borne outbreaks, there is not a working group formed to provide communication and information sharing among the various agencies and private sector in the state. New Mexico, like the nation, has several agencies responsible for different aspects of food safety and defense. The proposed task force will include all of these agencies and private sector partners. The private sector has become much more engaged due to recent far-reaching product recalls. They have a full understanding of the need to partner with the regulatory agencies and food defense education institutions like NMSU in becoming better prepared and to obtain the tools to conduct risk and vulnerability assessments, food defense plans, HAACP training, and Continuity of Operations plans. The food safety and defense arena is currently evolving due to proposed legislation at the federal level, increased import and export activity, and technology enhancements. The current economic conditions of the country and state will also force the regulatory agencies to evaluate alternatives given tight state and federal budgets challenges. These issues along with an increase in public notification and awareness are the primary reasons to organize a task force at the state level. This conference will be designed to provide the stimulus to create and maintain a program such as a working group dedicated to food safety and defense.